Immunoprofiling of Opioid Use Disorder Patients to inform structure-guided design of opioid-specific monoclonal antibodies

ABSTRACT: Immunoprofiling of Opioid Use Disorder Patients to inform structure-guided design of opioid-
specific monoclonal antibodies
The opioid use disorder (OUD) and opioid-related overdoses are a national emergency. Over >100,000
overdose deaths occurred in the period between April 2020 and April 2021, which are largely driven by fentanyl
alone or mixed with other opioids or psychostimulants. Since the initiation of the COVID-19 pandemic, there
has been an increase in non-fatal overdoses requiring hospitalization. These statistics clearly indicate that
approved pharmacotherapies are not sufficient in preventing or treating OUD and opioid overdose. Antigen-
specific monoclonal antibodies (mAbs) are isolated from the antigen, or by vaccine-induced polyclonal antibody
response. Compared to conventional treatment methods based upon small molecule-based
pharmacotherapies targeting the brain mu opioid receptor (MOR), mAbs bind and form a complex with the drug
molecule in circulation. Hence, administration of mAbs impedes drugs from crossing blood-brain-barrier
through sequestration of the molecules, blunting their CNS effects. Compared to MOR-ligands, mAb offer
longer lasting efficacy and no interference with off-target drugs. Therefore, the proposing study focuses on:
1) functional characterization of the human opioid-specific B cell receptor (BCR) repertoire paired with isolation
of opioid-specific mAb; 2) structure-guided design of humanized and human mAbs with greater efficacy and
selectivity. The research approach will involve complementary strategies to identify potential mAb candidates
including next-generation sequencing based-BCR sequencing, antibody display and antibody engineering, to
validate the hypothesis that pairing OUD- or vaccine-induced BCR genetic variability with structure-guided
antibody design will identify mAb with greater therapeutic potential. Moreover, the proposed study will inform
us of how OUD and vaccination introduces antigen-specific genetic perturbations in BCRs. With knowledge of
antibody structure, the result of this study will lead to generation of mAbs with improved affinity. To achieve
these goals, AIM 1 delineates the evolution of human BCR repertoire in OUD patients who are immunized with
a conjugated oxycodone-specific vaccine in Phase I clinical trials (NCT04458545) and unimmunized OUD
patients. AIM 2 tests the relevance of the opioid-specific Fab structure to the mAb efficacy and selectivity. The
results of the study will expand our understanding on the human opioid-specific antibody and B cell repertoire,
supporting structural-based antibody engineering to generate mAbs with high affinity. Moreover, the results can
accelerate the development of antibody-based strategy as an alternative and complementary solution treating
opioid overdose.

Public health relevance
PROJECT NARRATIVE An improved therapeutic method treating opioid overdoes is urgently needed, as the efficacy of naloxone is considered suboptimal due to the relative short half-life and inability to counteract opioid- induced pharmacological effects beyond the mu opioid receptor signaling pathway. The proposed study will investigate the evolution of B cell receptor repertoire in response to opioid use and vaccination, and combined with structure-based antibodies design, to delineate the B cell response against opioids and vaccination, and to generate opioid-specific monoclonal antibodies with improved affinity.